Role of mechanical stress in mitigating chemotherapy-associated bone loss

PROJECT SUMMARY/ABSTRACT
The Center of Biomedical Research Excellence in Matrix Biology administrative supplement will
support women’s health research in an IDeA state, specifically Idaho. The results of this study
will enhance our understanding of how bone health may be maintained for breast cancer
survivors and those who have undergone chemotherapy. This question is at the foundation of
concerns for women who have had breast cancer treatment and who are therefore at an
increased risk for osteoporosis and fracture. The risk of developing breast cancer increases with
age and is particularly high in women age 60 and older. Because of their age, these women are
already at an increased risk for osteoporosis. Case rates in Idaho are higher than the national
average, and much higher for some of the more rural counties within Idaho. Prevention and
therapeutic interventions are needed to minimize bone loss and reduce fracture risk in this large
and growing population. The proposed work will leverage resources available at Boise State
University, specifically the Biomolecular Research Core and the RNA sequencing laboratory.
The objective for this project is to investigate low-intensity vibration-induced improvements in
both DNA damage repair in mesenchymal stem cells, osteoblast differentiation, and
extracellular matrix production during cisplatin treatment. Results from this project will yield a
greater understanding of how external mechanical force is involved in maintaining bone health
during anti-cancer treatment. At the completion of the proposed experiments, we anticipate a
greater understanding of non-pharmacologic and targeted therapeutic interventions to decrease
long-term sequelae following chemotherapy. The results of the proposed work may reduce bone
fractures, cancer metastasis, and recurrence. Additionally, this administrative supplement will
expand the research and research capacity to conduct women’s health research in the state of
Idaho.

Public health relevance
PROJECT NARRATIVE This project will address the challenge of bone loss in cancer survivors and the increased risk of bone fractures. Bone fractures after chemotherapy is a major public health concern and this study will provide new information that may provide new treatments that will maintain bone health and prevent bone loss and lower the risk of fractures.